Development of direction selectivity in retina

The development of neural circuits involves a rich interplay between molecular cues and neural activity. This is
perhaps most well studied in the visual system, where several molecular interactions have been identified as
being critical for early establishment of coarse visual maps while both early spontaneous activity called retinal
waves prior to eye opening and visual deprivation after eye opening leads to map refinement.
We study this question in a direction-selective ganglion cells of the retina. Direction selective ganglion cells
respond strongly to an image moving in the preferred direction and weakly to an image moving in the opposite,
or null direction. Direction-selective ganglion cells are critical for driving ocular-motor reflexes that stabilize
images on the retina as we move through a visual scene as well as for sensing the movement of objects within
the visual scene. The preferred directions of direction selective ganglion cells cluster along four directions that
align along two optic flow axes, an organization we refer to as the direction selectivity map. The mechanisms
that instruct the development of this direction selectivity map are unknown.
Here we propose to use a combination of state-of-the-art two-photon calcium imaging, electrophysiology, and
transgenic mouse strategies to determine the mechanisms that underlie the development of the direction
selectivity maps. In particular, we will determine if neural signaling, either through gap junctions or retinal waves,
play a critical role in the formation of these direction selectivity maps. Finally, we will test candidate synaptogenic
molecules identified in an RNA-seq screen that may instruct the emergence of the functional inhibitory synapses
that underlie direction selective responses.

Public health relevance
Our work will determine what role early spontaneous activity and synaptogenic factors play in wiring up retinal circuits. In particular, we are studying the circuits that enable the retina to detect the direction of motion of an object in a visual scene, a canonical system for understanding neural computation. A detailed understanding of the organizing principles that govern the normal development of neural circuits will lead to understanding the origin of some neurological birth defects.